Impact of Aging on Mucosal Immune Protection in the Female Reproductive

Abstract
Not Applicable

Public health relevance
Narrative To improve morbidity and mortality in elderly women in the years following menopause, the changes in protection against infections that take place as women age need to be identified. This Supplement will investigate how aging affects defense mechanisms in the female reproductive tract (FRT) that protect against HIV infections. The identification of the mechanisms that control protection against FRT infections in elderly women will open new pathways for the development of prevention strategies.